Investigating Immunosuppression in Beta-catenin-mutated Hepatocellular Carcinoma for Improved Precision Medicine Therapeutics

PROJECT SUMMARY/ABSTRACT
Hepatocellular carcinoma (HCC) is the 6th leading cause of cancer-associated mortality in the United States, and
is rising due to chronic liver disease and its associated sequalae. Currently, the response rates to current
therapeutic paradigms consisting of immune checkpoint inhibitors (ICIs) remain low, and there exist an urgent
need for novel combinatorial therapies to improve patient mortality. Lack of response to current ICIs is mainly
due to a poor understanding of the tumor immune microenvironment (TIME) and how various HCC driver
mutations lead to specific immune phenotypes. Additionally, there currently exist no biomarker-driven
therapeutics for patient treatment stratification. ꞵ-catenin-active (encoded by mutated CTNNB1 oncogene) HCCs
represent approximately 26-35% of HCCs and respond poorly to ICIs due to ꞵ-catenin driving an
immunosuppressive TIME and limiting the effector function of lymphocytes important for anti-tumor immunity.
We have developed novel ꞵ-catenin-mutated HCC mouse models where mutant CTNNB1 is co-expressed with
either the proto-oncogene MET (ꞵ-catenin/hMet) or nuclear factor erythroid 2–related factor 2 (Nrf2) (ꞵ-
catenin/Nrf2). These models represent 11% and 10% of all clinical HCC cases, respectively. Our preliminary
studies demonstrate that ꞵ-catenin potentiates tumorigenesis in ꞵ-catenin-mutated HCC, and that directly
targeting ꞵ-catenin promotes an inflammatory response driving anti-tumor immunity. Based on these
observations, our overarching hypothesis is that ꞵ-catenin actively suppresses the adaptive immune response
in the TIME and targeting ꞵ-catenin or its downstream immunomodulatory factors may improve susceptibility to
ICIs. To investigate, I propose the following specific aims, which will uncover novel mechanisms of ꞵ-catenin
signaling in the HCC TIME, aimed at developing precision medicine therapeutics. Specific Aim 1: We will
determine the immune cells activated following ꞵ-catenin inhibition, and investigate whether there is in vivo
synergy combining ꞵ-catenin inhibition and ICIs through single-cell RNA-sequencing (scRNA-seq) and multiplex
immunohistochemistry. Thus, we will identify mechanisms of immunosuppression caused by ꞵ-catenin activation
in ꞵ-catenin-mutated HCC. Specific Aim 2: Based on our preliminary data showing interferon regulatory factor-
2 (IRF2) repression in ꞵ-catenin-mutated HCC, we hypothesize that ꞵ-catenin-mutated HCCs may be sensitized
to ICIs, or even show spontaneous tumor regression, upon re-expression of IRF2 as a result of enhanced
immune response. We will use synthetic biology approaches to selectively induce IRF2 expression at various
timepoints in tumorigenesis and monitor tumor burden. We will then use scRNA-seq on the lymphoid population
to identify cell types and states regulated by IRF2, and test combination of IFNg (which induces IRF2) + ICI as a
therapeutic modality. Contribution to Training: This proposal combines rigorous research training in liver
cancer biology, immuno-oncology, and advanced bioinformatic analyses with an excellent clinical education, to
aid my development as a future academic physician-scientist at the forefront of immune dysfunction in cancer.

Public health relevance
PROJECT NARRATIVE Hepatocellular carcinoma (HCC) is increasing in incidence due to the sequalae of chronic liver disease, with no significant recent improvement in patient survival due to a lack of biomarker-driven therapeutics. ꞵ-catenin- activation (mutated CTNNB1 oncogene) represents a molecular subset of HCC cases which are resistant to current immunotherapies. This proposal will investigate mechanisms of ꞵ-catenin activation driving immunosuppression in the tumor immune microenvironment, with our results paving the way for precision medicine therapeutics for ꞵ-catenin-mutated HCC.